Host cell reprogramming by human papillomavirus E7 proteins

PROJECT SUMMARY/ABSTRACT
Human papillomavirus (HPV)-encoded proteins engage cellular proteins to potently reprogram host cell signaling
pathways, in doing so establishing a cellular environment conducive to viral replication and persistence. The
HPV E6 and E7 proteins provide much of the viral reprogramming activity and, in the case of ‘high-risk’ HPV E6
and E7, so significantly disrupt cell signaling that they promote cellular transformation. Intensive research efforts
have identified many host cell binding partners of HPV E7, some that interact with HPV E7 proteins from most
virus genotypes and others that interact with only a subset of the HPV E7s. However, there is a major open
question regarding how many of the host cell targets of high-risk and low-risk HPV E7 proteins are required to
reprogram host cell signaling and, for high-risk HPV E7, to drive cellular transformation. We propose that the
RB1 and PTPN14 tumor suppressors are two essential E7 targets and their inactivation dominates the biological
activity of E7.
RB1 is a well-known target of many HPV E7 proteins that must be inactivated for high-risk HPV to cause cellular
transformation. High-risk HPV E7 proteins can degrade RB1, which is not a property of low-risk HPV E7s. It is
not known how RB1 degradation, in addition to binding, enables high-risk HPV E7 to alter cell signaling or to
promote cellular transformation. Moreover, RB1 inactivation is necessary but insufficient for the transforming
activity of high-risk HPV E7. We discovered that a second target of many HPV E7 proteins is PTPN14. Our
published and preliminary data show that HPV E7 proteins degrade PTPN14 and that PTPN14 degradation
activates YAP1 signaling. We also found that high-risk HPV E7 must degrade PTPN14 and activate YAP1 to
immortalize primary human keratinocytes.
Our hypothesis is that RB1 degradation and PTPN14 degradation are independent activities of high-risk HPV
E7 proteins that cooperate to reprogram the host cell and drive cell transformation. The aims are 1) to determine
how degradation of RB1 and PTPN14 contribute to host cell reprogramming and 2) to determine how degradation
of PTPN14 and RB1 contribute to HPV E7 transforming activity. Our research will determine how HPV E7
reprograms host cell signaling and how inhibiting essential activities of HPV E7 could limit cell growth. By testing
whether a subset of the many proposed targets of HPV E7 underlie most of its biological activity, we will advance
the understanding of viral oncoprotein activity, updating the model to reflect the established concept that altering
a small number of host targets is sufficient for cellular transformation.

Public health relevance
PROJECT NARRATIVE The human papillomavirus E7 protein reprograms host cell signaling to enable virus replication and drive carcinogenesis. Although HPV E7 proteins interact with many host cellular proteins, the minimal determinants of the HPV E7 biological activity have not been identified. The goal of this proposal is to determine the extent to which degradation of the tumor suppressors RB1 and PTPN14 accounts for the cell reprogramming and carcinogenic activity of cancer-associated HPV E7 proteins.